Nanoparticle-targeted therapeutic development for glomerular diseases

Project Abstract
The long-term goals of this project are to translate to the clinic innovative kidney-targeted therapeutics for
glomerular disease. The interdisciplinary and translational team is led by a Biomedical Engineer with mentors
and collaborators in Cell Biology, Nephrology, and a Pharmacology. End-stage kidney disease (ESKD) affects
over 800,000 Americans, substantially increasing health and financial burdens related to dialysis or renal
transplants. ESKD is preceded by chronic kidney disease (CKD), which arises from varying etiologies, including
diabetes and hypertension, affecting 37 million Americans and over 800 million individuals worldwide. Taken
together, proteinuric kidney diseases account for 90% of all ESKD at an estimated cost of $20 billion per year in
the US. Substantial health disparities exist in the diagnosis and treatment of CKD, wherein African Americans
are four times more likely than white Americans to progress to ESKD and represent 35% of all patients on
dialysis. In addition to substantial socioeconomic risk factors, genetic and epigenetic alterations contribute to
these disparities. Prior work by the collaborators at MSSM (Campbell, Wong) and others identified injury of the
glomerular-resident podocytes as a partial driver of proteinuric CKD and progression to ESKD. Published studies
by the lead PI (Williams) and mentor (Jaimes) discovered that safe, biocompatible polymeric mesoscale
nanoparticles (MNPs) exhibit 26-fold selective targeting to the kidneys over any other organ. Those published
studies used this MNP system to load various payloads, with 9 total published studies ranging from small
molecules to biologics (peptides, siRNA, mRNA) and demonstrated their therapeutic efficacy in five separate
rodent models of renal disease. We produced innovative data demonstrating an unexpected localization of these
particles to the podocytes in the context of proteinuric glomerular disease, as opposed to prior studies showing
targeting to the tubular epithelium within the kidneys. In this work, we will capitalize on this finding by delivering
a therapeutic payload to the glomerulus in rodent models of glomerular disease. We will deliver the therapeutic
amiloride, an FDA-approved diuretic used to treat hypertension. Studies have found that amiloride has off-target,
podocyte protective effects, though clinical trials demonstrated limited efficacy in part due to poor pharmacology
of the drug with respect to the kidney. Here, we propose to encapsulate amiloride within MNPs and to study the
pharmacology and therapeutic efficacy of this formulation in several rodent models of glomerular disease. We
plan complementary in vitro and in vivo studies to understand the mechanistic function of amiloride-loaded
MNPs, as well as to investigate the unexpected finding of glomerular MNP targeting in the context of glomerular
disease. We anticipate future work may pursue the encapsulation of more potent novel amiloride analogs, as
well as pre-clinical large-animal studies, to enable clinical trials. In the long term, we expect this work will reduce
morbidity and mortality associated with the progression of CKD to ESKD. The active collaborative/mentoring
team expects this work to lead to competitive NIH R01 applications.

Public health relevance
Per Funding Opportunity Announcement (FOA) Number RFA-MD-24-001 Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.